Training Program in the Molecular Bases of Eye Disease

Project Summary
The Training Program in the Molecular Bases of Eye Diseases (MBED) is postdoctoral training program in the
Department of Ophthalmology at Harvard Medical School (HMS) that aims to attract and mentor talented and
motivated basic scientist trainees in vision research. The program is comprised of 33 faculty members who
conduct research in a range of areas using a broad array of methods and models. The mentors represent a
diversity of relevant disciplines including ocular immunology, vascular biology, neurobiology, regenerative
medicine, gene therapy, bioinformatics, ocular surface, and drug delivery, to name a few. Moreover, the
research faculty are focused on a number of important ocular pathologies such as age-related macular
degeneration, glaucoma, retinal degenerations, corneal inflammation, wound healing, dry eye and corneal
transplantation. This diversity provides a wide selection of training opportunities.
Since it was first established in 1997, the MBED program has trained 93 trainees, four of whom have been
under-represented minorities. Most of our trainees have continued some aspect of vision research. Their
productivity is illustrated by their publications records. Each year the Training Grant supports three trainees for
one year; each trainee spends at least two years total in training. A majority of the MBED faculty has extensive
research experience, strong publication records, and successful records of mentoring. Each faculty member
has an appointment in the department of Ophthalmology at HMS and is affiliated with Schepens Eye Research
Institute of Mass Eye and Ear, Mass Eye and Ear, Harvard Medical School, Children’s Hospital or the Joslin
Diabetes Research Center. All mentors are funded and most are supported by the National Eye Institute (NEI).
The goal of the MBED Program is to provide trainees with expertise in cellular, biochemical and molecular
approaches as well as knowledge and proficiency with relevant disease models. Importantly, the training
provided by the MBED Program instills the ability to recognize and the address the important clinical and basic
research questions challenging ophthalmology. The faculty are highly committed mentors as evidenced by the
quality and success of their trainees. The location of the affiliated institutions in Boston provides an outstanding
research environment with access to outstanding facilities and resources. Training includes dedicated
mentoring, full-time research, didactic courses, ample opportunity for collaboration and networking, workshops
on soft skills, as well as instruction in grant and manuscript writing and review, communications skills, the
responsible conduct of research, and methods for enhancing reproducibility. Thus, MBED training
encompasses all elements required to produce independent and successful vision researchers who have deep
knowledge and understanding of the basic and clinical principles that are key to identifying and solving
important ophthalmic problems.

Public health relevance
Narrative The International Agency for the Prevention of Blindness’s Vision Atlas reports that as of 2021 there are 43 million people living with blindness and 295 million people who have moderate to severe vision impairment. In the US there are 12 million people with visual impairment, including one million people who are blind. The Training Program in the Molecular Bases of Eye Diseases has as its goal to train scientists who will use a wide range of disciplines to elucidate the causes of visual impairment and blinding diseases with the aim of developing methods for earlier diagnosis, more effective treatments, means for prevention and eventually to develop cures.